SEMINARS GIVEN BY STANLEY FIELDS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. September 2008 Oxford University October 2008 Center for Advanced Biotechnology and Medicine, Rutgers/UMDNJ October 2008 SUNY Stony Brook March 2009 University of British Columbia June 2009 Seattle Biomedical Research Institute